Diabetes, Obesity, and Metabolic Complications

This institutional research training program provides opportunities for promising PhD students and post-
doctoral fellows to train for careers in biomedical research related to Diabetes, Obesity, and Metabolic
Complications. During its first four years (2015-present), this training grant provided support four ten trainees –
including five pre-doctoral trainees (two of whom received their PhD degrees) and five post-doctoral fellows
one of whom is supported by a Diversity Administrative supplement. The central features of the Program
include intensive research in the laboratory of the participating faculty member and didactic training in basic
science, translational research, and clinical investigation. Research areas span a wide range of scientific
disciplines – including physiology, biochemistry, pharmacology, neurosciences, genetics, toxicology, and
molecular medicine. The faculty mentors are highly productive researchers who serve as Principal
Investigators on peer reviewed research grants from the National Institutes of Health as well as private
foundations such as the American Diabetes Association and the Juvenile Diabetes Research Foundation. Pre-
doctoral trainees are recruited from the Graduate Program in Life Sciences (GPILS) at the University of
Maryland Baltimore. Post-doctoral trainees are recruited from leading research laboratories – primarily within
the United States. The mentors’ research teams employ a wide variety of scientific methods including modern
biochemical and molecular studies of hormone action. Expertise in biochemistry, cell biology, molecular
biology, human genetics, neurobiology, toxicology, and physiology are all well represented by the faculty.
Primary facilities are located in the University of Maryland School of Medicine – the oldest public medical
school in the United States. During its first four years of existence, faculty from the following academic
Departments have mentored trainees: Medicine, Physiology, Anatomy & Neuroscience, and Obstetrics &
Gynecology. This Program has been funded to support two PhD students and two post-doctoral trainees.

Public health relevance
Diabetes affects a large number of people in the US, and increases the risk of chronic complications including cardiovascular disease, blindness, kidney failure, and non-traumatic extremity amputations. Obesity is even more common, and is associated with an increase in the risk of type 2 diabetes as well as cardiovascular disease and multiple additional morbidities. The University of Maryland Baltimore has established this institutional research training program to train the next generation of biomedical scientists to conduct innovative research to address the high degree of high unmet medical need due to diabetes and obesity.